Enhanced Echinobase: A Community Genomics Research Resource For The Future

SUMMARY OF OVERALL COMPONENT
Enhanced Echinobase: A Community Genomics Research Resource for the Future
Echinobase (Echinobase.org) is the central repository and web-accessible resource for all of the diverse
genomic data types produced by biologists working with echinoderms. Echinobase was cloned from Xenbase
to enhance database functionality, web application capabilities, and performance, all at a fraction of the cost of
doing this independently. A key added feature developed through this work are database modules that support
curation and searches of gene expression data. The look and feel of Echinobase is unique, and is tailored to its
user base including the creation of a multi-species viewer. The website provides rapid integrated capabilities
for search, view and download of a range of datatypes to empower their own research. Echinoderms are one
of only three major phyla within the deuterostomes, and therefore the species within this clade encompass a
large taxonomic diversity of body plans. Species of echinoderms are powerful model systems for
understanding the processes by which the genome controls development. The strengths of this experimental
model will continue to make it a preeminent system for the analysis of the genomic control of embryogenesis
and for analyses of developmental gene regulatory networks (GRNs) to reveal the mechanistic links between
the genome and development and consequently the genomic basis of congenital diseases.

Public health relevance
PROJECT NARRATIVE FOR OVERALL COMPONENT Echinobase is a model organism knowledgebase for the echinoderm research community. Genomic resources and links out to other databases are provided through a design that facilitates rapid user access to information. Features have been guided by the community and developed upon FAIR principles.